Determining the Incidence, Risk Factors and Biological Drivers of Irritable Bowel Syndrome (IBS) as Part of the Constellation of Post-Acute Sequelae of SARS-CoV-2 Infection (PASC) Outcomes

Irritable bowel syndrome (IBS) affects an estimated 10-15% of the U.S population and induces morphologic and
physiological abnormalities significantly impairing one’s quality of life and is the most common diagnosis of a
heterogeneous group of gastrointestinal disorders of gut-brain interaction (DGBI). The risk of IBS following an
acute gastrointestinal (GI) infection is approximately 9%, and has been linked to numerous bacterial, protozoan,
and viral infections. Notably, SARS-CoV-2 infection elicits a wide range of GI symptoms, including diarrhea,
nausea, and vomiting, with reports of acute GI symptoms occurring in up to 61% of patients. Initial studies have
shown persistent GI symptoms lasting up to 5-6 months post-acute infection in 40-44% of SARS-CoV-2 patients.
Given the scale of the ongoing pandemic and reports of chronic GI symptoms after acute SARS-CoV-2 infection,
determining how this pathogen will impact the incidence or exacerbate IBS symptoms, while playing a major role
in the development of post-acute SARS-CoV-2 (PASC), known colloquially as Long COVID, is imperative.
However, to date, there is a dearth of studies that have assessed the development of post-acute GI disorders
following SARS-CoV-2 infection. The Arizona CoVHORT, an ongoing, prospective, longitudinal study of the
acute and long-term impacts of SARS-CoV-2 infection on adults, provides the critical extant infrastructure
required to efficiently investigate the health impacts of the pandemic. Using this cohort infrastructure, we propose
the following aims: (1) Estimate the incidence of IBS following SARS-CoV-2 infections compared to non-
infected participants. To determine the incidence of IBS following SARS-CoV-2 infection, we will employ data
from the Rome IV IBS diagnostic questionnaire to compare rates of new onset IBS among participants who
tested positive for SARS-CoV-2 to those who did not, while controlling for confounding factors such as age,
gender, and ethnicity comorbidities and concomitant stress at the time of infection. (2) Determine the role of
pre-existing IBS on the development and severity of PASC. We will follow IBS participants who reported a
diagnosis (1) prior to March 2020, (2) before a SARS-CoV-2 infection, and (3) those who report no history of
infection to determine their ongoing and long-term symptoms over 2-5 years, including assessment of risk factors
and confounders. (3) Establish mechanisms of IBS following SARS-CoV-2 infections including differences
in the fecal microbiome composition and function, the host’s anti-commensal immune response to the
fecal microbiome, and targeted/untargeted serum protein biomarkers among SARS-CoV-2 exposed and
unexposed, who do and do not develop incident IBS. We will collect blood and stool samples and employ
shotgun metagenomics, host-microbiome directed IgG-seq and IgA-seq, and high dimensional serum proteomic
arrays to explore novel mechanisms, phenotypes, and biomarkers associated with PASC-IBS. PASC will impact
the individual health of millions of Americans over the next several years, and to date, limited studies have
examined potential long-term effects of SARS-CoV-2 on GI outcomes specifically.

Public health relevance
PROJECT NARRATIVE PASC, or the post-acute sequalae of SARS-CoV-2 infection, will impact the individual health of millions of Americans over the next decade, yet few studies have examined the potential long-term effects of SARS-CoV- 2 on gastrointestinal outcomes (PASC-GI) such as Irritable Bowel Syndrome (IBS). This research aims to determine the burden the SARS-CoV-2 infection has for both incident and pre-existing IBS and other PASC-GI outcomes. Using a multi-omics approach this study will also investigate the underlying mechanistic pathways critical to ascertain, diagnose, and ultimately treat these disabling PASC-GI conditions.